A Translational Randomized Clinical Trial of Varenicline Sampling to Promote Smoking Cessation and Scalable Treatment Dissemination

Abstract: Smoking is the leading risk factor for preventable morbidity and mortality, and smoking cessation
remains the primary goal for population-based tobacco and cancer control. Many smokers lack resources to
initiate and sustain a successful quit attempt. For the last decade we have been testing innovative approaches
for delivery of pharmacotherapies that allow smokers to try evidence-based cessation medications and self-
determine their goals and pace for cessation. Medication sampling is a brief, concrete, and easily understood
exercise that often induces attitudinal shifts in favor of quitting smoking, and more importantly promotes quit
attempts and actual cessation. Medication sampling is also favored by healthcare providers, augmenting their
brief advice as per clinical guidelines. We have conducted three trials of nicotine replacement therapy (NRT)
sampling (N=157, 849, 1245), all of which were remote, and some of which have been applied within medical
settings. Each trial demonstrated increases in cessation behavior. Our prior work on NRT sampling creates a
compelling question as to whether varenicline sampling would have similar, or potentially better, effects.
Varenicline is inarguably the most effective single cessation medication available, superior to other
monotherapy options. As a prescription medication, whether varenicline is suitable for sampling is unclear but
worth testing empirically. On one hand, unstructured use, over a brief time, may not deliver sufficient
pharmacologic benefit. Prescription delivery incurs its own barriers to widespread dissemination (which can be
overcome). On the other hand, much like NRT sampling, it could provide a tangible cue to action that provides
psychological engagement (motivation, confidence, autonomy) to sustain subsequent use and ultimately
enhance cessation. A trial of varenicline sampling is not merely a routine extension of NRT trials, yet the
significance is even more compelling given evidence of its unique benefits. We therefore propose a
randomized clinical trial with primary aims to determine the 1) use, 2) consequences (on cessation), and 3)
mechanisms of varenicline sampling. A demographically diverse sample of 648 smokers will be recruited
across South Carolina and randomized (2:1:1) to receive I) a 4-week sample of varenicline, II) a 4-week supply
of NRT, or III) nothing. Thus, our design is strengthened by both active and inactive comparison groups.
Outcomes will be assessed through 6 months of follow-up. We employ innovations in mobile health
technologies throughout to enhance methodological rigor, including remote biological verification of smoking
behavior. If varenicline sampling were to show promise through this and future trials, this would offer great
dissemination appeal to physicians, quitlines, etc in that, much like our NRT work, varenicline sampling could
be a pragmatic strategy to engage more smokers in better treatments, sooner. Ultimately, the population
impact of medication/varenicline sampling could be profound, offering a significant and measurable opportunity
to lessen the impact of tobacco on public health and to reduce the risk, incidence and mortality of cancer.

Public health relevance
Project Narrative: Several prior studies have shown the potential value of medication sampling to promote population-wide smoking cessation engagement, but whether these same benefits apply to varenicline, arguably the best single-agent cessation medication, is unclear. This randomized clinical trial will offer a test of varenicline sampling as a method to engage all smokers in the quitting process. Ultimately, the population impact of medication/varenicline sampling could be profound, offering a significant and measurable opportunity to lessen the impact of tobacco on public health.